Cell type-specific molecular mechanisms by which glucose availability regulates cell mechanics and function

SUMMARY/ABSTRACT
The proposed study aims to address the following three critical questions in cell mechanobiology field for better
understanding of how cells translate external biochemical cues to regulate their function via modulation of cell
mechanics. (1) What are the molecular mechanisms by which extracellular glucose levels alter cell mechanics
and functions? Glucose is an essential nutrient for virtually all types of cells including immune cells and epithelial
cells to support their survival and proper function. Glucose level varies in local tissues due to differential
consumption rate by cells and/or altered interstitial fluid pressure in pathological conditions such as inflammation
and cancer. Dynamic rearrangement of actin cytoskeleton is critical for cell physiology. Cells spend 50% of their
energy to support actin cytoskeleton rearrangement, which determines cell mechanics and function. Cell
mechanotypes include cell shape, deformability, and contractility. We have reported that extracellular glucose
level alters cell mechanics and we will further elucidate the underlying molecular mechanisms by which glucose
metabolism regulates cell mechanotype changes. (2) How cell mechanics is regulated in spatiotemporal
framework? Cell mechanotype alterations span many length scales and timescales. It is intuitive that cell
mechanotype changes can happen promptly after triggered by external cues as cytoskeleton remodeling and
post-translational modification of myosin activating signaling pathway can happen within seconds to minutes.
However, we don't understand how dynamically cell mechanotype changes are regulated over time in subcellular
resolution. We are in a unique position to investigate the persistency, reversibility, oscillation, and memorization
of altered cell mechanotypes. (3) Are there shared signaling axes or cell type-specific axis to regulate cell
mechanics in different cell types? Our published and preliminary data shows that glucose-induced changes in
cell mechanics and function are cell type-dependent. M1φ is similar to MCF10A cells, while M0φ and M2φ are
similar to MDA-MB-231 cells in terms of their mechanotype changes in response to extracellular glucose level:
no significant changes were observed from M1φ and MCF10A, while increased stiffness and contractility were
observed from M0φ, M2φ, and MDA-MB-231 cells with high glucose levels. We will investigate the shared or
distinct molecular mechanisms by which cell mechanics are regulated. Successful completion of the proposed
work will significantly improve our understanding on the effects of extracellular glucose levels on cell mechanics
and function. Furthermore, this novel knowledge will serve as a basis of future translational studies utilizing the
cell mechanotypes for effective therapeutic options on various diseases including cancer and infectious diseases.

Public health relevance
PROJECT NARRATIVE Regulation of cellular mechanical properties, or mechanics/mechanotypes, by cytoskeleton rearrangement and motor protein activity is an energy-extensive procedure, but plays critical roles in cell physiology. However, there is a knowledge gap on what external biochemical signaling cues can regulate cell mechanotypes and what are the underlying molecular mechanisms. Identification of these signaling cues from microenvironment and its detailed molecular mechanisms will deepen our understanding to basic cell biology and provide foundation for therapeutic use of cell mechanotypes in diverse diseases.